University of Washington/Fred Hutch Center for AIDS Research

ABSTRACT
This application is a competing renewal of the UW/Fred Hutch CFAR, a Tier 3 CFAR in its 30th year and one of
the original CFARs launched in 1988. The UW/Fred Hutch CFAR is a multidisciplinary and multi-institutional
consortium including the University of Washington (UW), Fred Hutchinson Cancer Research Center (Fred
Hutch), Center for Infectious Disease Research, Infectious Disease Research Institute, Seattle Children’s, and
the University of Hawai’i (minority affiliate). Our CFAR has grown from 75 members in 1988 to 736 today, with
members from 45 UW departments, all five Fred Hutch Divisions, and connections throughout Seattle, a global
technology and innovation hub. NIH 2017 HIV funding to our five Seattle partners exceeds $169 million, an
increase of 11% over the past five years and with representation from all NIH Institutes that co-sponsor the
CFAR program; non-NIH HIV funding exceeds $365 million. The UW/Fred Hutch CFAR has catalyzed
substantial growth in research infrastructure, domestic and international partnerships, research impact, and the
development of emerging HIV researchers (with a return on investment on CFAR developmental awards of
1320%), demonstrating high added value and aided by significant institutional financial contributions. We have
recently completed a 10-step strategic planning process for this application, seeking input from our members
and advisory committees and intentionally evaluating and strengthening our structures and policies for
improvement and prioritization. Key innovations for this proposal include our new Director, selected by a
Succession Oversight Committee; doubling funding to our Developmental Core; merging two Cores and
integrating two additional Cores into others, which will gain efficiencies and set new directions; building on our
strong foundation in clinical and basic science; incorporating a robust monitoring and evaluation program;
committing to the growth of new leaders across our Cores/SWGs; and defining a new Vision Statement with five
Themes that underpin our work going forward: Global Impact, Multidisciplinary Science, Innovative and Cutting-
Edge Expertise, Enabling Environment, Next Generation of HIV Research Leaders. Our overarching Strategic
Aims are: (1) Catalyze multidisciplinary HIV research to achieve impact on the global epidemic, with work from
bench to bedside to populations (and back); (2) Grow new researchers, research leaders, infrastructure, and
resources to expand innovative multidisciplinary work to change the trajectory of the global HIV epidemic. Our
Cores and SWGs will have multidisciplinary cross-connections, will provide novel science and services, and will
include three Clinical Science Cores (Clinical Cohort and Comorbidity Research; Behavioral Science;
Implementation Science), three Basic Science Cores (HIV-Associated Malignancies; Immunology; Retrovirology
and Molecular Data Science), three cross-cutting Cores (Administrative; Developmental; Biometrics), and three
Scientific Working Groups (Cure; Adolescent Health; eHealth). We are proud of our CFAR and its successes to
date, and we eagerly are looking ahead to future CFAR-supported research, collaboration, and innovation.

Public health relevance
PROJECT NARRATIVE The UW/Fred Hutch Center for AIDS Research (CFAR) is a multi-institutional consortium based in Seattle which catalyzes new HIV research and develops new research leaders across the multidisciplinary spectrum of basic, clinical, epidemiologic, statistical, sociobehavioral, and implementation science expertise necessary to bend the curve of the global HIV epidemic. During 30 years of continuous funding, the UW/Fred Hutch CFAR has facilitated substantial growth in research infrastructure, domestic and international partnerships, research impact, and the development of emerging HIV researchers (with a return on investment on CFAR developmental awards of 1320%), demonstrating high added value and aided by significant institutional commitment. Through the work of our nine Cores and three Scientific Working Groups, we aim to expand multidisciplinary HIV research and grow new researchers, research leaders, infrastructure, and resources to achieve impact on the global epidemic, with work from bench to bedside to populations.